Capsid assembly mechanisms of Kaposi Sarcoma associated herpesvirus

Project Summary
Capsid assembly is an essential step in production of an infectious herpesvirus, yet little is known on how the
process begins and the protein oligomeric states and intermediate interactions required to complete the final
mature capsid. Disruptions in capsid assembly result in aberrant capsids unable to assemble or package viral
DNA, resulting in noninfectious virus. The major proteins involved in herpesvirus capsid assembly are
generally conserved across alpha, beta, and gammaherpesvirus subfamilies which provides an opportunity to
develop pan-herpesvirus therapeutics. Yet to date, little has been done to capitalize on this process;
furthermore, most capsid assembly research focuses on alphaherpesvirus, HSV-1. This proposal focuses on
understanding capsid assembly of gammaherpesvirus, Kaposi sarcoma herpesvirus (KSHV), the leading
cause of cancer in HIV positive individuals. I will develop an in-vitro capsid assembly assay to monitor capsid
kinetics and oligomeric states required for capsid nucleation and maturation. I hypothesize KSHV capsid
assembly is a highly dynamic process requiring multiple conformations of capsid protein intermediates to
generate a capsid capable of packaging a large DNA genome. I will purify KSHV capsid proteins via
baculovirus expression and systematically determine the proteins required for capsid formation and kinetics via
dynamic light scattering and negative stain electron microscopy. In addition, I will evaluate the oligomeric
states of capsid proteins individually and protein intermediates to determine 1. The proteins required for capsid
nucleation and 2. How KSHV scaffold oligomerizes to produce unique B-capsid morphologies. I further
hypothesize that the divergence of SCP between subfamilies is a result of variations in the capsid assembly
pathway. For example, it is thought SCP is not required for alphaherpesvirus capsid assembly but is required
for gamma and betaherpesviruses. I hypothesize SCP is required for efficient C-capsid assembly, as loss of
SCP results in decreased infectious virus and C-capsid formation in alpha, beta, and gammaherpesvirses;
however, the exact mechanism is unclear and seems dependent on cellular environment. I will use the in-vitro
capsid assemble assay and live virus mutagenesis to study the function of SCP in capsid maturation. I will
utilize previously generated KSHV SCP null viruses to quantify capsid structural integrity with atomic force
microscopy to determine at what stage capsid assembly stalls, as well as the role of phosphorylation on SCP’s
function. These aims will highlight the similarities and difference between alpha and gammaherpevirus viruses,
providing the evidence required for inhibitor development and a scalable in-vitro assay for testing inhibitors. I
will develop a robust skillset in biophysical techniques which coupled with my expertise in molecular virology
will allow me to successful complete these aims and develop the skills required to run my own independent
research lab.

Public health relevance
Project Narrative Capsid assembly is an essential step in the herpesvirus replication cycle; however, little is understood on how herpesvirus capsids nucleate and mature to form infectious C capsids. The proposed investigation will develop an in-vitro platform to study the gammaherpesivus, Kaposi Sarcoma Herpesvirus Virus (KSHV), capsid kinetics and assembly requirements to determine the similarities and differences between herpesvirus subfamilies. KSHV reactivation is detrimental to the immunocompromised and there are no specific treatment options available; this study will develop a scalable assay to testing herpesvirus capsid inhibitors to prevent lytic replication and limit viral induced disease.